Project 3: Characterization of the biology of non-responders using Imaging and molecular analysis to inform treatment

The I-SPY2 trial is a multicenter, Phase II neoadjuvant platform trial for high risk, early-stage breast cancer designed to
rapidly identify new treatments and treatment combinations with increased efficacy on a standard-of-care background
(sequential weekly paclitaxel followed by doxorubicin/cyclophosphamide (T-AC) chemotherapy). It is considered the
archetype of the adaptive platform trial, enabling multiple novel treatment regimens to be evaluated simultaneously,
targeting treatment to breast cancer subtypes defined by on hormone receptor (HR) and Human Epidermal Growth Factor
Receptor-2 (HER2) expression, and MammaPrint (prognosis signature) high risk status. Since launching in 2010, 24 new
therapies or combinations have been tested, and 7 found to significantly improve pathologic complete response (pCR),
leading to several definitive phase III trials. However, with this success came the realization that within the 8 predefined
subtypes not everyone benefitted. Through this program project we designed and implemented a next generation I-SPY2.2
trial to advanced personalized medicine in early breast cancer treatment with a patient-centric approach to clinical drug
development. I-SPY2.2 allows the optimization of individual treatments by escalation or de-escalation of therapy based on
treatment response measured by an MRI-based assessment, doing so in the context of a trial that efficiently evaluates
novel potential first-line regimens. Project 3 has been instrumental in advancing our understanding of the dynamics of the
biology of response and treatment resistance and enhancing our ability to better target agents to individual biology by
improving stratification of high-risk tumor biology. In collaboration with Project 4, we developed more refined response-
predictive subtypes, ‘RPS,’ that modelling suggests will result in improvements in pCR rates of over 15%. Characterizing
and understanding the biology and dynamics of treatment non-response in stage 2 and 3 breast cancer provides the
mechanistic basis for the rational design of treatment switching strategies and development of composite measures to
assess treatment response and recurrence risk to guide clinical decision-making. In our current proposal and based of our
earlier work in the program project and beyond, we now hypothesize that a comprehensive approach to understand non-
response across multiple omics levels (Aim 1) and integrated with dynamic imaging features (from Project 2), will
provide the best strategy for robust results for either escalation or de-escalation in the course of the trial treatment (Aim 2;
for Project 1). We have extended our experimental platforms with several that are based on liquid biopsies (such as
ctDNA, immune cytokine typing and exosome analyses of protein/phosphoproteins). This, in combination with an
extension of our technologies already employed in our current grant, will give us the best option to prioritize alternative
therapies in case of early, or later observed non-response (Aim 3). Druggable targets thus revealed will inform Project 4
for innovative drug selection. The dynamic changes in biomarkers in tumor or blood observed will provide the robustness
to escalate or de-escalate treatment for patients with observed early non-response, or robust response. The ultimate goal is
to get all high-risk patients to a complete response and thereby significantly reducing chance of recurrence and death.

Public health relevance
In women treated with drugs for early breast cancer before surgery, the best result is when the tumor completely disappears, because this means the risk of the cancer returning is greatly reduced. In this project, we use genomics and medical imaging to look for signs that will help us determine if a treatment is working or not. We are also working to understand the biology of why some cancers are difficult to treat and look for ways that might make them vulnerable to other treatments.